Targeting G alpha q/11 in Uveal Melanoma

PROJECT SUMMARY/ABSTRACT Uveal melanoma (UM) is the most common intraocular tumor in adults and accounts for approximately 5% of all melanomas. UM metastasizes primarily to the liver in 50% of patients, and currently there are no suitable treatment options. In contrast to most cutaneous melanomas, which contain mutations in BRAF or NRAS, ~90% of all uveal melanomas contain activating mutations in either GNAQ or GNA11, which code for the Gαq and Gα11 subunits of heterotrimeric G proteins. These two proteins are 90% homologous at the amino acid level and stimulate common signaling pathways. The activating mutations are almost always seen at the Q209 or R183 residues and render Gαq/11 constitutively active when bound to GTP due to the loss of its intrinsic GTPase activity. Introduction of the GNAQ-Q209L mutant, but not wild-type GNAQ, into human or mouse melanocytes results in anchorage-independent growth and gives rise to heavily pigmented tumors in vivo. Gαq/11 is involved in many downstream signaling pathways and its constitutive activity in UM leads to an increase in the activation of MAPK, Akt and the small GTPases RhoA and Rac1, which stimulates the transcription of growth promoting genes. We believe that it would be advantageous to directly inhibit oncogenic Gαq/11 and prevent the activation of these various cell proliferating pathways. To this end, we have tested the compound QIC, known to specifically inhibit wild type Gαq/11, and found that is also capable of inhibiting oncogenic Gαq/11 found in UM. Based on these results, we hypothesize that we can use Gαq/11 inhibitors such as QIC to provide a better mechanistic understanding of the role that oncogenic Gαq/11 plays in UM. To test this hypothesis, we will: 1) further characterize the mechanism by which Gαq/11 specific inhibitors inhibit oncogenic Gαq/11 proteins in vitro; 2) assess the effects of Gαq/11 inhibition on downstream signaling in uveal melanoma cells; and 3) determine the effect of Gαq/11 inhibition on uveal melanoma cell growth and migration. Taken together, these studies will enable a better mechanistic understanding of the role of Gαq/11 in uveal melanoma and set the stage for the use of Gαq/11 inhibitors in animal models.

Public health relevance
PROJECT NARRATIVE This research will play a vital role in providing a better understanding of how a key mutation in the GNAQ/11 gene causes uveal melanoma. Not only will it highlight specific mechanisms of pathogenesis, but it will also help set the stage for the development of a new treatment strategy for patients with uveal melanoma. This in turn may help to enhance patients' overall health by lengthening their lifetime and ridding them of uveal melanoma through non-invasive means.